Determining the role of OXR1 in aging and Alzheimer's disease

PROJECT SUMMARY/ABSTRACT Despite identifying some of the genetic risk factors for AD, the precise etiology of most cases of Late-Onset Alzheimer's disease (LOAD) is unknown. Subsequently, therapies to treat AD have been largely unsuccessful. Two important risk factors for AD, aging, and diet, with aging being the greatest risk factor for AD, remain largely ignored. Dietary restriction (DR), one of the most robust interventions to slow aging, also delays the onset of Alzheimer’s disease (AD) in multiple models across species. We exploited the short lifespan and powerful genetic tools in D. melanogaster to identify that mustard (mtd)/oxidative stress resistance protein 1 (OXR1) in neurons is required for the protective effects of DR on lifespan. Importantly, we have observed that OXR1 protects against age-related neurodegeneration in fly and human-induced pluripotent stem cell (iPSC) derived models of neurodegenerative diseases. The mechanisms by which OXR1 protects against neurodegeneration remains unclear. We observed that inhibiting OXR1 reduces retromer proteins while enhancing retromer function, rescues the deleterious effects of inhibiting OXR1. Furthermore, we found that alterations in OXR1 and several retromer proteins are associated with an increased risk of AD in humans using proteomics data from over 1000 AD patients from the Accelerating Medicines Program-Alzheimer’s Disease (AMP-AD) network. Here, we propose to test the hypothesis that OXR1 enhances retromer function to slow aging and neurodegeneration using fly and human iPSC models of AD. In the first aim, we will determine the mechanisms of regulation of OXR1 and how that influences aging and age-related neuronal damage. In the second aim, we will determine the DR-dependent role of OXR1 in enhancing retromer function and the role of retromer in mediating the protective effects of DR. To determine the mechanism by which OXR1 enhances retromer function upon DR; we will use proteomics to determine and characterize the protein binding partners of OXR1. In the third aim, we will test the role of OXR1 in protecting against neurodegeneration in models of AD, and by enhancing retromer function. We will test whether OXR1 modulates AD pathology in fly models that overexpress human tau or amyloid β (Aβ). We will overexpress OXR1 and retromer proteins in forebrain cholinergic and cortical neuron derived AD iPSCs and measure AD endpoints: Aβ42/40 accumulation, cell death, and electrophysiology. Because OXR1 regulates retromer function in the fly, we will evaluate whether this regulation is conserved in human AD-derived iPSCs and carry out omics approaches to identify key signaling pathways mediating OXR1’s protective effects. By characterizing retromer function and protein networks regulated by OXR1 and their role in aging and age-dependent neurodegeneration, we will provide novel targets for developing therapeutics to slow AD-related pathologies and extend healthspan. Furthermore, we will determine whether reuse of proteins through retromer under nutrient limiting conditions is neuroprotective and slows aging.

Public health relevance
PROJECT NARRATIVE Given that aging is the biggest risk factor for the onset of Alzheimer’s disease (AD) and related dementias, there is an urgent need to identify genes that explain the link between aging and AD. We have identified that oxidative resistance 1 (OXR1) and downstream retromer function are necessary for the protective effects of dietary restriction on slowing aging and neurodegeneration in the fly models, and alterations in retromer pathway are associated with increased AD risk in humans. The proposed research is relevant to public health as we will determine the conserved mechanisms of action of OXR1 in enhancing retromer function and neuroprotection across species and determine its relevance as a potential therapeutic target for AD.